Prospective RCT of Obstructed Defecation Surgery: Comparing Transvaginal Rectopexy, Ventral Mesh Rectopexy and POP Repair (PROD Trial)

Obstructed defecation (OD), defined as incomplete emptying of stool, is a widely prevalent
disorder in women’s health and resulting in major quality of life (QOL) and healthcare burden.
Successful management has been impaired, historically, by deficiencies relating to both
diagnosis and treatment. First, there has been a persistent misconception that OD in the
absence of dyssynergia (i.e., uncoordinated contraction of pelvic floor) results from prolapse of
the posterior vaginal wall (‘rectocele’) and improves after its repair. In fact, prior studies have
confirmed that this form of OD results from support defects involving the rectum rather than
vagina (8-10), and moreover that rectocele repairs are unreliable in relieving OD symptoms.
Recent work from our center confirmed rectal detachment and hypermobility to be the major
determinants of OD in the irrespective of the presence of a rectocele. Secondly, traditional
diagnostic modalities to asses rectal support as the source of OD are expensive (e.g. MRI
defecography) and/or invasive (e.g. anal manometry), and often generate findings with unclear
clinical correlation and impact on care. Finally, available surgeries to repair rectal support
defects have been limited to invasive transabdominal or perineal methods, typically involving
mesh implantation and reserved for severe cases, e.g. those with overt rectal prolapse.
Laparoscopic or open ventral mesh rectopexy is the most widely accepted operation to stabilize
rectal support.
We are testing the hypothesis that OD symptoms in the absence of dyssynergia primarily
result from deficiencies in rectal support and that patients presenting OD symptoms with or
without vaginal prolapse undergoing our new diagnostic evaluation and surgical treatment will
have improved outcomes relative to the current standard of care at 2 years after surgery. Our
study is designed to evaluate primary and secondary outcomes relating to the two rectopexy
procedures on OD at 2 years follow up across two institutions. This clinical data will be
complemented by a computational modeling approach that aims to provide insight into the most
likely contributors to OD symptoms, i.e. vaginal versus rectal support defects. Aim 1: Compare
occult rectal hypermobility as measured using posterior compartment dynamic ultrasound imaging
versus MR defecography. Posterior compartment dynamic ultrasound is a novel approach for
identifying the underlying anatomic cause of OD in women suffering from OD symptoms without
coexisting functional bowel disorders (e.g. normal BM frequency and stool type, and absence of
dyssynergia). Aim 2: Compare anatomic, functional, and health-related quality of life outcomes
in female subjects with moderate to severe OD symptoms, and rectal hypermobility diagnosed by
ultrasound, who are randomized to minimally invasive transvaginal rectopexy versus abdominal
ventral rectopexy at 2 years after surgery. Aim 3: Develop and validate a computational finite
element model and statistical shape modeling approach to describe the mechanics of normal
defecation and the role of rectal and vaginal support deficiencies in causing OD symptoms.

Public health relevance
Obstructed defecation (OD), defined as incomplete emptying of stool, is a widely prevalent disorder in women’s health, occurring in roughly 25% of constipated women and resulting in major quality of life (QOL) and healthcare burdens. Our group has developed a cheap, bedside diagnostic approach for OD that better identifies patients that need surgery, and a minimally invasive, mesh-free surgical approach to treat those patients that causes less morbidity, and improves outcomes based on our small preliminary studies. The goal of this proposal is to do a more extensive clinical trial to demonstrate the effectiveness of these approaches.